Liquid biopsy cell-free DNA analysis to monitor sepsis

Project Summary / Abstract
The goal of this proposal is to define a five-year plan to prepare Nicholas P. Semenkovich, M.D., Ph.D., to
become an independent physician-scientist studying applications of cell-free DNA as a novel biomarker in sepsis.
He obtained his M.D. and Ph.D. degrees at Washington University in St. Louis, where he studied intestinal and
immune epigenetic changes induced by the gut microbiome. After clinical training in Internal Medicine at the
Brigham and Women’s Hospital, Dr. Semenkovich pursued subspeciality training in Endocrinology and
Metabolism, and joined the lab of Dr. Aadel Chaudhuri to focus on the applications of cell-free DNA to
understudied diseases. There he has developed and applied key new techniques and deep learning algorithms
for analyzing cell-free DNA using epigenetics, which serve as the basis for the aims in the proposal.
Key guidance for this project will be provided by Dr. Semenkovich’s mentor, Dr. Chaudhuri. Dr. Chaudhuri is a
physician-scientist and an internationally recognized expert in cell-free DNA. He has a passion for and dedication
to training physician-scientists as they prepare for independent careers. In addition. Dr. Semenkovich has
assembled an advisory committee of faculty with expertise in sepsis, critical care, and immunology, who will
provide crucial scientific and career guidance. Washington University in St. Louis is an ideal place to receive this
training, with outstanding resources and expertise readily available.
The primary research goal of this proposal is to develop and advance cell-free DNA as a novel biomarker with
predictive and prognostic roles in sepsis. Dr. Chaudhuri’s lab has previously characterized how cell-free DNA
can be leveraged in a range of malignancies. Dr. Semenkovich’s proof-of-concept work has provided the first
clear evidence that cell-free DNA can be used to predict complications and early end-organ damage in sepsis.
He is developing machine learning methods to identify septic patients at risk of complications and will test those
hypotheses in silico, in vitro, and in vivo. These efforts promise to fundamentally change our understanding and
management of sepsis and enable potential clinical trials and immunomodulatory interventions to treat sepsis.
This K08 award will provide the necessary resources and skills that Dr. Semenkovich will require to become a
successful independent investigator.

Public health relevance
Project Narrative This K08 Career Development Award Proposal describes the skills and further training that the PI, Dr. Nicholas P. Semenkovich, M.D., Ph.D., will develop over the next five years to become an independent physician scientist with unique expertise in sepsis and applications of liquid biopsy cell-free DNA as a predictive and prognostic biomarker. Successful accomplishment of the proposed aims will establish a new paradigm for the study of sepsis over its temporal presentation, including its catastrophic complications, and will define a new framework for triage, management, and potential early intervention. Furthermore, the mentorship and training plan serve to develop a candidate with expertise in basic science research and clinical acumen, a combination that is critically important for future translational breakthroughs.